Cancer and Aging Reflections for Elders (CARE): A Geriatric-Specific Psychotherapy for Older Adults with Cancer

PROJECT SUMMARY
By 2040, 20% of the population will be over 65. Sixty percent of cancer diagnoses and 70% of cancer deaths
occur in older adults, with rural older adults at a higher risk of developing and dying from cancer than their urban
peers. Additionally, 73% of cancer survivors are older adults. Depression is an important concern for older adults
with cancer, as estimates of those with depressive symptoms are as high as 27%. Depression often interferes
with treatment decision making and treatment adherence. In rural areas, up to 25% of older adults have a
diagnosable psychiatric illness. Additionally, older adults often have subsyndromal depression, with recent
population estimates of up to 40% in medically ill patients. Even the presence of mild depressive symptoms is
associated with significant mortality. These individuals are at increased risk for social isolation with minimal
access to mental health care despite a willingness to utilize these services. We developed a novel intervention,
the Cancer and Aging: Reflections for Elders (CARE) Intervention, to treat depression and distress in older
cancer patients. CARE is a manualized, five session telephone intervention which can easily be disseminated.
CARE uniquely focuses on aspects of aging and cancer by: 1) integrating development theory of aging with
reappraisal theory, and 2) incorporating feedback from older cancer patients. This unique tailoring is designed
to help older adults negotiate age specific developmental tasks and utilize reappraisal strategies important for
successful aging. As a result, CARE has the potential to be more effective than “off the shelf,” standard
psychotherapeutic interventions, applied to this population. Data from the pilot RCT indicated that CARE is
feasible and effective. This study tests the efficacy of the CARE intervention in a large, two arm, RCT. We will
partner with the Cancer Support Community (CSC) to recruit through CSC’s local affiliates in areas with large
rural populations and to deliver the interventions via telephone through the CSC-identified social workers. 476
subjects will be randomly assigned to two arms: Arm 1-the CARE Intervention and Arm 2- a Social Work and
Supportive Counseling (SWSC) Intervention. Both interventions will consist of 5 sessions (45 mins) and 4 briefer
booster sessions (30 mins). CARE has the potential to impact the field on both a theoretical and clinical level.
Importantly, CARE was tested by phone to reach older adults who are geographically isolated and was
developed so different types of professionals (e.g., master’s level psychologists, social workers, clergy,
psychiatry nurses) could provide the intervention. If found to be effective, CARE could be a cost effective, easily-
implemented, first-line treatment for depressive symptoms for older adults with cancer.

Public health relevance
PROJECT NARRATIVE The proposed study is relevant to public health in that it addresses a rapidly growing group of patients with cancer, older adults (≥70 years), with the goal of delivering psychotherapy (i.e., the CARE intervention) to older adults with limited access to mental health services. Research indicates that older adults with medical illnesses and depression have difficulty adhering to aftercare, are not typically connected to mental health services, and are at high risk for completing suicide, yet they continue to be overlooked in routine clinical encounters; these risks are elevated among individuals living in rural areas. Thus, this study is aligned with the NCI’s goals of improving the reach and quality of cancer care for older adults, with an emphasis on rural populations.